Elucidating pBAF-complex functions by chemical genetics and epigenome editing

Abstract
The eukaryotic genome is highly organized within the nucleus, controlling many cellular
processes. Chromatin regulators set up, erase, and maintain chromatin states and
organizational patterns to control gene expression, pluripotency, differentiation, and
development. One class of chromatin regulators, the mSWI/SNF family, comprises three main
complexes in stem cells, canonical BAF (cBAF), polybromo-associated BAF (pBAF), and
GLITSCR-associated BAF (gBAF). The three forms share common subunits, but each also has
distinct subunits. How these complexes differ in function and specificity and the contribution of
the unique subunits needs to be better elucidated. We will determine these differences by
focusing on separating pBAF complex functions and specificity. We will define the roles of pBAF
complexes using loss-of-function and gain-of-function studies. Biochemical and genomics
approaches using degradable alleles and mutant histone lines will allow us to determine
transcription and chromatin changes when these complexes are lost. Using an inducible dCas9-
based targeted recruitment strategy that I developed, we will determine transcription and
chromatin changes mediated by these complexes when they are gained at a new site in the
genome. Since chromatin dysregulation can lead to various human diseases, including
developmental and neurological diseases and cancer, understanding normal and dysfunctional
mechanisms of chromatin regulation is of great importance to human health.